Vermont Genetics Network - Vermont INBRE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To help develop the ability to work collaboratively and remotely on bioinformatics among the Bioinformatics Cores of the INBREs and COBREs in the Northeast.